Regulation, evolution, and function of promoter-associated non-coding RNAs

PROJECT SUMMARY / ABSTRACT
LEIGHTON CORE, Ph.D. – UNIVERSITY OF CONNECTICUT=
Proper regulation of RNA transcription is essential for dynamic control of cellular responses to environmental
and developmental cues. Dogmatic shifts in the fields of transcription regulation and RNA biology have led us
to appreciate that noncoding RNAs (ncRNAs) can regulate transcription of protein-coding genes by diverse
mechanisms such as recruitment of activators or repressors to gene promoters and enhancers or by affecting
RNA processing. In addition to the role of the RNA, the act of transcription itself can positively or negatively
influence promoter activity when transcription patterns overlap. These observations suggest that regulation of
ncRNA biogenesis adds an intricate layer of control to overall gene expression levels. This proposal aims to 1)
identify the mechanisms that regulate ncRNA production and destruction, 2) determine ncRNA effect on local
protein-coding gene transcription and RNA processing, and 3) investigate the ability of ncRNAs to as
capacitors for evolution of new genes. The major obstacles in understanding the full impact of ncRNAs on
gene transcription is comprehensive identification of non-coding transcripts and methods to functionally classify
them. The work proposed here will develop new experimental and computational methods for comprehensive
identification of transcripts and a classification scheme that will predict function. We will experimentally test our
functional predictions and use the results to inform further revision of our classification system. We will focus
on ncRNAs that overlap with or emanate from protein-coding promoters to determine if they are regulated by
independent signaling pathways and whether their level of production influences expression from the protein-
coding gene. Finally, using an evolutionary model to identify nucleotide changes associated with altered
ncRNA transcript production and processing, we will identify and test mechanisms that are involved in ncRNA
regulation and how they may serve as a platform for gene birth during evolution. These studies will create
functional transcript annotations that will be a primary resource for those studying gene expression in any
context. In addition, our investigation of ncRNA regulation and evolution will serve as foundational work
towards determining how these transcripts affect development, disease, and acquisition of new phenotypes.

Public health relevance
PROJECT NARRATIVE LEIGHTON CORE, Ph.D. – UNIVERSITY OF CONNECTICUT ncRNAs are involved in regulating every phase of gene expression from transcription factor recruitment to RNA transcription, processing, stability, and translation. Intense efforts are still required to identify all species of ncRNAs and their diverse functions in regulating gene expression. This proposal is aimed at identification and annotation of ncRNAs involved in transcriptional regulation using a combined nascent and mature RNA sequencing strategy followed by functional tests of how ncRNAs affect regulation of nearby genes. These studies will generate important resources and represent foundational framework for studying ncRNA function.